Development and Use of Network Infrastructure for High-Throughput GWA Studies

[unreadable] DESCRIPTION (provided by applicant): Linking biorepositories of patients in healthcare delivery systems with electronic medical records (EMRs) is an efficient strategy for high-throughput genome wide association (GWA) studies, as phenotype, covariable and exposure data of public health importance can be economically abstracted and pooled across delivery systems to facilitate the large numbers of subjects needed for GWA studies of each phenotype. Key obstacles to the success of this strategy remain. In this project, which will use population-based genomic and phenotype data from a well characterized population served by a delivery system which captures virtually all health care encounters in its data bases. Researchers from Group Health Cooperative's Center for Health Studies, the University of Washington, and the Fred Hutchinson Cancer Research Center will address these obstacles by pursuing the following specific aims: [unreadable] [unreadable] 1. Informed by results from targeted focus groups, implement a consensus process with key stakeholders to develop recommendations concerning consent, data sharing, and return of research results to subjects. [unreadable] 2. Work together with other network sites to develop a virtual data warehouse (VDW) analogous to that used in the Cancer Research Network, and extend natural language processing (NLP) to pathology, radiology, and clinical chart notes. [unreadable] 3. Develop and test strategies to determine whether each candidate EMR-based phenotype is sufficiently valid to pursue analyses of GWA data, and develop statistical methods that explicitly account for heterogeneous phenotype validity within and between sites. [unreadable] 4. Perform a series of GWA analyses in the GHC biorepository and linked biorepositories. 4a: Alzheimer's disease (AD). 4b: Carotid artery atherosclerotic disease (CAAD). 4c: Complications of statin use, including elevations of CPK and muscle pain. [unreadable] [unreadable] Through cooperation with other investigators and the NHGRI, this work will facilitate development of policies and procedures to realize the incredible potential of EMR-linked biorepositories for GWA studies to improve understanding, prevention and treatment of chronic diseases and illnesses. Specific GWA research will allow us to explore both etiologic research (AD and CAAD progression) and pharmacogenetics (statin therapy). The implications of this portfolio of research extend far beyond the specific phenotypes we have chosen to emphasize; we expect this work represents the beginning of a large and productive enterprise. [unreadable] [unreadable] [unreadable] [unreadable]